Lung epithelial cell specification in human pluripotent stem cells

Lung transplantation, the only definitive treatment for end-stage lung disease, remains
hampered by severe complications and a shortage of donor organs. One potential
alternative for at least some diseases where the epithelium is specifically affected is stem
cell or cellular replacement therapy. Application of this type of therapy is still far away,
however. Prerequisites for cellular therapy are an unlimited supply of the correct epithelial
progenitors and an efficient engraftment procedure. In this proposal, we focus primarily on
the first goal, and use generic injury models to demonstrate the potential of these cells.
To address the issue of an unlimited supply of potential airway progenitors, we focused
on embryonic stem cells (ESCs) and induced pluripotent stem cells (iPSCs), collectively
termed human pluripotent stem cells (hPSCs). We describe here the generation from
hPSCs of a population of putative fetal lung distal tip progenitors (pDTPs) that can be
expanded continuously (up to now 18 months) and efficiently repopulates most or all
lineages in bleomycin-injured lungs of immunodeficient NSG mice. Furthermore, these
cells can be converted to cells with all the characteristics of basal cells (BCs), the stem
cells of the airway, which, however, showed more limited expansion. Despite the fact the
pDTPs engrafted in the airways of bleomycin-treated NSG mice, the derived BC-like cells
did not engraft, suggesting that BCs may not possess engraftment capacity or that
bleomycin is not an appropriate injury model for these cells. The goal of this proposal is to
molecularly characterize both cell populations and evaluate their potentials in a variety of
injury models. The specific aims of the proposal are:
Aim 1: Molecular and in vitro characterization of pDTPs and BC-like cells
Aim 2. In vivo potential of hPSC-derived pDTPs and BC-like cells.
Aim 3. Culture conditions and clonality of pDTPs.

Public health relevance
Project Narrative For many epithelial lung diseases curative treatment is, except for lung transplantation, not available, and cell replacement therapy may be an option in the future. Prerequisites for cellular therapy are an unlimited supply of the correct epithelial progenitors, and an efficient engraftment procedure. In this proposal, we focus primarily on the first goal, and use generic injury models to demonstrate the potential of these cells.